Mechanisms underpinning meiotic spindle formation and behavior

Administrative Supplement for R35 GM142537 (PD/PI: Balboula): “Mechanisms underpinning meiotic
spindle formation and behavior”
From Parent R35 GM142537
Project Summary:
Meiosis is a specialized set of cell divisions that produce haploid gametes. During meiosis I (MI) in females,
bipolar spindle formation and positioning within the oocyte must be regulated tightly to ensure faithful
chromosome segregation and proper genome inheritance. In somatic mitotic cells, bipolar spindle formation and
positioning rely on a centrosome pair, each of which contains two centrioles. Interestingly, meiotic oocytes lack
centrioles and, hence, lack classic centrosomes. Meiotic oocytes, instead, contain numerous microtubule (MT)
organizing centers (MTOCs) that are organized, by largely unknown mechanisms, to establish two spindle poles
(polar MTOCs). The traditional view was that, in mammalian oocytes, MTs (and their associated proteins) are
the only cytoskeletal components responsible for organizing such MTOC spindles. However, recent data suggest
that F-actin is also involved in spindle bipolarity regulation. How F-actin interacts with MTs to regulate polar
MTOC organization during MI represents a critical gap in our understanding of how the meiotic spindle is built.
We recently identified a novel, functionally different, class of MTOCs (mcMTOCs) and found that spindle
maintenance at the oocyte center is regulated by two opposing forces (mcMTOC-mediated MTs vs. F-actin). We
also recently observed that ~50% of spindles are not assembled centrally. To date, such peripheral spindle
assembly was unobservable owing to technical limitations associated with spindle fluorescence (i.e. live
imaging). To circumvent this, we generated a Cep192-eGfp reporter mouse model enabling spindle tracking
wherever it is assembled. Strikingly, peripheral spindle formation is typically followed by spindle migration
towards the center – a previously undocumented phenomenon. Understanding the molecular mechanisms
regulating this corrective developmental event represents a major gap in our knowledge of meiotic spindle
spatiotemporal regulation during MI. This proposal lays the foundations for our long-term goal: To understand
how two critical events during MI — bipolar spindle assembly and positioning — are regulated, in the absence
of centrioles, to ensure faithful chromosome segregation. To do so, we will utilize state-of-the-art approaches,
including transgenic mouse models, genetic constructs, laser ablation, and cutting-edge imaging, to tackle three
critical goals: (i) determine how F-actin interacts with MTs to organize polar MTOCs during bipolar spindle
building, (ii) establish the mechanism(s) by which the peripheral acentriolar spindle migrates to the oocyte center,
and (iii) determine whether differences in biochemical compositions of mcMTOCs vs. polar MTOCs underlie their
functional differences. Given that chromosome segregation errors (very common during MI) lead to aneuploidy,
the leading genetic cause of developmental disorders and miscarriage, these studies have the potential to
significantly advance our basic understanding of two fundamental processes — spindle formation and positioning
— during MI whilst simultaneously shedding light on why MI is notoriously error prone.

Public health relevance
Administrative Supplement for R35 GM142537 (PD/PI: Balboula): “Mechanisms underpinning meiotic spindle formation and behavior” From Parent R35 GM142537 Narrative: Meiosis is a specialized set of cell divisions that generate male (sperm) and female (egg) gametes. In females, meiosis is associated with high rates of chromosome segregation errors, which lead to miscarriage, infertility, and developmental disorders such as Down’s syndrome. This project uses mouse oocytes as a model system to understand the basic molecular mechanisms that regulate female meiosis, thereby shedding a light on why this process is notoriously error prone.